NYR-Diabetes Research Center (NYR-DRC)

Abstract
The mission of the Administrative Core is to provide overall management, direction and supervision of
NYR-DRC activities. This includes all financial, personnel, research and enrichment activities of the NYR-DRC.
The Administrative Core’s primary objectives are to ensure efficient and seamless integration of Center
activities both within and external to Einstein, thereby coordinating our efforts with the administrative staff at
Mount Sinai and other affiliated institution members in the New York area. By reducing administrative burdens
placed on NYR-DRC faculty, this allows investigators the greatest potential for success in their research
efforts. In addition, the Administrative Core provides financial and personnel management associated with the
NYR-DRC. This Core is central to the organization and management of the Enrichment Program. In addition,
the Administrative Core is specifically responsible for allocation and oversight of NYR-DRC resources in
coordination with policies and procedures defined by the Executive Committee and input from the External
Scientific Advisory Committee. This includes implementation of Core objectives, review of membership,
organization of the research base, functional management of the Enrichment and Pilot & Feasibility Study
Program, and maintenance of the NYR-DRC website. The Administrative Core is also responsible for the
development and organization of initiatives such as the institutionally supported Microgrant program and the
Center’s interface with Mount Sinai and other regional institutions in management of budgetary (direct and
indirect costs), material transfers, animal and human studies approvals and compliance with all university
policies and procedures. In these efforts, Dr. Jeffrey Pessin serves as the NYR-DRC Director and will oversee
all NYR-DRC activities. Dr. Pessin is assisted by the Associate Directors, Drs. Andrew Stewart and Meredith
Hawkins, the NYR-DRC Executive Committee and the Core Facilities Management Committee. Together these
individuals ensure the seamless coordination of all NYR-DRC activities with other Institutional Centers and
facilities and other initiatives to enhance the mission of the NYR-DRC. The Administrative Core proactively
integrates the NYR-DRC with the efforts of the other DRCs in the Northeast and provides a mechanism for the
inclusion of investigators from other institutions as full Center members.

Public health relevance
Relevance The mission of the NYR-DRC is to promote and advocate research to understand the molecular, cellular, tissue and integrated physiology of dysregulated metabolism. The Administrative Core serves as the central node for assuring the seamless operation and effectiveness of the diverse functions of the NYR-DRC focused on developing new knowledge and novel approaches to the treatment potential cure for diabetes and related metabolic diseases.